IMMUNOBIOLOGY OF CARCINOGENESIS

Lymphokines, interleukins, and other immunological hormones, i.e., the secretory bioregulatory macromolecules of lymphocytes, macrophages, and other leukocytes, are being studied to define their effective anticarcinogenic and tumor cell growth inhibitory activities. Leukoregulin, a lymphokine isolated during the course of this project, can prevent carcinogenesis and inhibit tumor cell growth. Anticarcinogenic action is direct, irreversible and occurs without cytotoxicity. Inhibition of tumor cell growth is primarily reversible but can become irreversible due to increased susceptibility of preneoplastic and neoplastic cells to cytolytic destruction by natural killer cells resulting from leukoregulin target cell interaction. Leukoregulin at very high concentrations is also directly cytolytic for tumor cells. The direct-acting anticarcinogenic activity of leukoregulin is more potent than the tumor cell inhibitory activity; but by also being able to increase target cell sensitivity to the cytoreductive action of naturally cytotoxic lymphocytes, leukoregulin can be an effective homeostatic mechanism for control of carcinogenesis at its later stages of development.Leukoregulin-induced changes in plasma membrane permeability are partially dependent upon extracellular ionic calcium and are accompanied by increased calcium flux, the rapid opening and closing of plasma membrane single ion channels and translocation of protein kinase C from the cytosol to the plasma membrane which may be important events in the molecular pathway, resulting in inhibition of tumor and other abnormal cell proliferation by this immunologic hormone. The recent identification of the ability of leukoregulin to increase the uptake of pharmacologically active molecules in leukoregulin-sensitive cells provides a new area of potential therapeutic usefulness for this lymphokine and a new approach to drug delivery - biotherapeutic targeted drug delivery and pharmacologic up-regulation by target cell-specific cytokines.